Reprogramming adult murine Müller glia via L-Myc expression

PROJECT SUMMARY
In response to damage from injury or disease, lost neurons in the adult mammalian retina are
irreplaceable which can lead to visual impairment including blindness. Some non-mammalian vertebrates,
such as teleost fish, can regenerate the retina in response to damage via the Müller glia. In teleost fish, Müller
glia will respond to signals from damaged neurons by asymmetrically dividing to produce retinal progenitor
cells. These progenitor cells then differentiate into neuronal cell types and functionally restore tissue.
Mammalian Müller glia are quiescent and do not display regenerative capacity in response to damage.
However, mammalian Müller glia demonstrate some cell state plasticity and can be reprogrammed into
induced pluripotent stem cells (iPSC) in vitro. Mammalian Müller glia likely have the capacity for
reprogramming but lack the cell intrinsic- or extrinsic-signaling necessary to do so.
I have found that overexpression of L-Myc, a robust reprogramming factor used to reprogram many
somatic cell types to iPSCs, leads to cell cycle re-entry in adult mammalian Müller glia in ex vivo retinal tissue.
Using murine retinal explant tissue as an injury model, I will characterize the effects of L-Myc overexpression
on proliferation and dedifferentiation in mammalian Müller glia. I hypothesize that L-Myc overexpression in
Müller glia leads to direct and indirect changes in gene expression and chromatin accessibility that reprogram
Müller glia toward a progenitor-like state. To test this hypothesis, I will first characterize the effects of L-Myc
expression on proliferation. I will do so by defining the interval of proliferation as it relates to L-Myc expression
and determining if Müller glia or their descendants are able to divide repeatedly following L-Myc
overexpression. Next, I will characterize the effect of L-Myc overexpression in Müller glia on cell identity and
gene regulation. Using data integration of RNA-sequencing, ATAC-sequencing, and CUT&Tag of FACS sorted
L-Myc overexpressing Müller glia, I will identify gene regulatory networks affected directly or indirectly by L-Myc
overexpression and identify changes in cell state.
Combining Müller glia, a highly promising population within the mammalian retina for reprogramming,
and L-Myc, a potent reprogramming factor to promote proliferation and dedifferentiation, creates an ideal
scenario to reveal targets to promote regeneration in the mammalian retina through the analysis of gene
regulatory networks activated or inhibited by L-Myc overexpression. Regardless of the cell state changes that
occur in response to L-Myc overexpression in Müller glia, this project will reveal what signaling barriers exist
that prevent tissue regeneration via Müller glia in the mammalian retina. This study is designed to identify
future targets for genetic therapies to promote restoration of tissue and visual function after injury in the
mammalian retina, which one day could lead to treatments for currently untreatable visual diseases.

Public health relevance
PROJECT NARRATIVE Damage to the mammalian retina through injury or disease causes irreversible vision loss, unlike in other vertebrates, which restore tissue function through Müller glia-based regeneration. I propose to overexpress a robust cell reprogramming factor, L-Myc, in murine Müller glia in retinal tissue to understand the capacity of these cells to change cell state in an injury model. The results of this study will provide insight on what genetic signals are sufficient to induce cell state changes in mammalian Müller glia, what signals are inhibitory to this process, and ultimately identify targets for future genetic therapies to restore vision after injury.